Role of CNNM2 in Neuronal Mg2+ Homeostasis, Function and Development

PROJECT SUMMARY
Magnesium (Mg2+) is the fourth-most abundant ion the human body. Participating in over 300 enzymatic
pathways, intracellular Mg2+ is crucial for life, affecting fundamental cellular process such as metabolism, DNA
replication, mRNA transcription and protein translation. Consequently, the amount of intracellular Mg2+ in cells
and in the body are tightly regulated, within narrow sub-millimolar ranges. Alterations in Mg2+ homeostasis are
associated with numerous clinical phenotypes, including cardiovascular disease, diabetes mellitus, hypertension
as well as neuropsychiatric and neurodevelopmental disorders like anxiety, intellectual disability and
developmental delay. Cyclin M2 (CNNM2) is a transmembrane protein that mediates cellular transport of Mg2+.
The protein is highly expressed in the kidney and the brain, where it is principally expressed in neurons.
Proteomic studies by the Runnels laboratory have demonstrated that CNNM2 is part of protein complex. Human
mutations in CNNM2 give rise to a monogenic disease called Hypomagnesemia, Seizures, and Intellectual
Disability (HSMR) Syndrome. HSMR patients excrete more Mg2+ from the kidney into the urine, causing Mg2+
deficiency, are also obese and have seizures, motor skills difficulties, intellectual disability and developmental
delay. The HSMR symptoms are consistent with intracellular Mg2+ levels being critical for neuronal development
and function. The importance of intracellular Mg2+ in neurobiology is supported by a wealth of literature, but
surprisingly despite its significance, Mg2+ homeostasis remains poorly understood in neurons. Moreover, CNNM2
neuronal expression and its protein composition remains undefined. We will address this gap in knowledge and
hypothesize that i) mouse and human CNNM2 will have a specific neuronal expression and protein composition
and ii) CNNM2 mutations will disrupt Mg2+ flux in both mouse and human neurons, and be associated with
developmental, synaptic and proteomic changes that are rescued once intracellular Mg2+ levels are restored. To
test this hypothesis, in Aim 1 we will determine i) Cnnm2 expression in the developing and adult mouse brain
using complementary approaches (IHC, western, GFP transgenic) and ii) the composition of CNNM2 complex
in moue and human induced neurons (iNs). In Aim 2, we will rigorously define the function and impact of CNNM2
isogenic KO and HSMR disease-causing mutations on neuronal development and function. Mg2+ levels, neurite
and synaptic development, and Ca2+ signaling will be examined in mouse and human iNs. Proteomics will
determine expression changes and rescue experiments will uncover which phenotypes are Mg2+ specific. By
using both mouse and human stem cell lines, we will be able to determine whether CNNM2 function is conserved
across species. Unbiased, high throughput methodologies (robotics, high content CellInsight imaging platform,
proteomics) will be utilized to increase productivity, statistical power and rigor. These studies will provide critical
understanding of how intracellular neuronal Mg2+ homeostasis is maintained and how its disruption affects
neuronal function and development and contributes to CNS disorders, including epilepsy and HSMR.

Public health relevance
PROJECT NARRATIVE Mg2+ plays an essential role in neurobiology but despite its importance, how neuronal Mg2+ homeostasis is regulated and how its dysfunction contributes to clinical symptoms remains unexplored. In this proposal CNNM2, a Mg2+ transporter, is leveraged as a biologically relevant entry point to understand these questions. CNNM2 expression and protein composition is characterized in both mouse and human neurons and the effect of disease-relevant mutations on neuronal development is determined.